GENETICS OF PHYSIOLOGICAL SCHIZOPHRENIA PHENOTYPES

The genetic transmission of eye tracking abnormalities will be studied. Also, the P50 auditory evoked potential (an EEG abnormality), phenotypes abnormal to schizophrenics, and about 50% of the unaffected relatives will be studied. These phenotypes will be used to determine a quantitative liability to schizophrenia, which will be used as a sensitive phenotype to search for predisposing gene(s) for schizophrenia. Linkage and linkage disequilibrium will be employed using data from: 1) moderately sized Utah pediagrees; 2) a fully ascertained sample form the island population of Palau, Micronesia, and 3) schizophrenics and their first degree relatives form the isolated inbred populations of Dahestan, Russia. This is a "core lab only" protocol.